Foundation Models for Human Functional Neuroimaging with Applications to Psychiatric Disorders

Project Abstract
Our project aims to harness the transformative potential of Foundation Models (FMs) in the fields of clinical
neuroscience and psychiatry. In recent years, a successful new paradigm for building artificial intelligence
systems has emerged: train a single model on a vast amount of heterogeneous, unlabeled data and adapt it to
various applications. While such FMs have demonstrated unprecedented capabilities in fields as diverse as
natural language processing and medicine, their potential for decoding the complexities of human functional
brain imaging data remains largely untapped. Crucially, conventional data analysis methods for functional brain
imaging (fMRI) are hampered by the need for large, labeled datasets, their inability to capture the intricate
spatiotemporal dynamics associated with psychopathology, and the recurrent issues of heterogeneous data
and class imbalance in clinical brain imaging studies. To address these challenges, we propose to develop an
integrated framework that combines FMs with Explainable Artificial Intelligence (XAI) techniques. This
framework will be used to analyze large open-source human brain imaging datasets and phenotypic data
across multiple psychiatric disorders. Moreover, our innovative FMs will provide a robust framework for
effectively integrating heterogeneous datasets and addressing the recurrent issue of class imbalance in clinical
brain imaging studies. Building on our highly promising preliminary results, our team, working with the Stanford
Center for Foundation Model Research – a leading institute dedicated to FM research – is uniquely positioned
to achieve the following research objectives: First, we will develop FMs specifically designed for large, open-
source task-free fMRI datasets such as the HCP, Lifespan Connectome, Human Connectomes Related to
Human Disease, and ABCD, among others. Second, we will fine-tune FMs to investigate multiple highly
prevalent psychiatric disorders and predict clinical symptom severity. Lastly, we will identify personalized
neurobiological features and associated brain networks underlying these disorders. Our FMs will obviate
the need for large, labeled datasets, exhibit robustness against class imbalance, and generalize to
heterogeneous data. Our approach is theoretically grounded, building upon unifying models of
psychopathology that emphasize the role of key control brain networks in multiple psychiatric disorders. By
pioneering state-of-the-art FMs tailored for functional brain imaging, our work aims to equip researchers with a
transformative toolset for investigating the neurobiology of a range of psychiatric disorders within a unified
framework. This will lay the groundwork for more precise diagnostic and treatment strategies in psychiatry.
Moreover, the open sharing of FMs and associated data analysis code will catalyze future research,
significantly amplifying the impact and scope of our work.

Public health relevance
Project Narrative In response to the NIMH Notice of Special Interest (NOT-MH-21-175), this project aims to harness large-scale data and develop and apply cutting-edge Artificial Intelligence techniques to advance our understanding of the complex neurobiology underlying highly prevalent psychiatric disorders. We will analyze large-scale human brain imaging and phenotypic data from the Human Connectome Project and related datasets to identify personalized neurobiological markers and predict symptom severity across multiple conditions. By creating powerful and adaptable computational tools, this research will lay the groundwork for more precise diagnostic and treatment strategies, potentially transforming mental healthcare outcomes.